Genetic and genomic analysis of electron transport chain Complex II functions in mammalian skin development

Project Summary
The electron transport chain (ETC) is central to cellular metabolism, facilitating ATP synthesis through the
establishment of an electromotive proton gradient across the inner mitochondrial membrane. Pioneering work
in mitochondrial biology has revealed an additional role for the ETC in cellular signaling, both through the
generation of reactive oxygen species (ROS) and through modulation of epigenetic and post-translational
modifying enzyme activity by TCA cycle metabolites. While considerable effort has been made towards
characterizing the effects of ETC dysfunction in tumorigenesis and human disorders of central metabolism, the
role of individual ETC complexes during tissue morphogenesis remains largely unknown. Though previous
work by our lab has shown that epidermal loss of ETC Complex III results in embryonic lethality and severe
barrier defects through impaired epidermal differentiation, whether this defect reflects a requirement for
Complex III activity, or a specific dependency on Complex I or II remains unclear. To answer this question, we
have generated two novel mouse models with epithelial-specific deletions of Ndufs2, a critical Complex I
component, and Sdhd, a crucial subunit of Complex II. Intriguingly, our preliminary data has shown that Ndufs2
is largely dispensable for normal hair and skin development, while Sdhd deletion results in numerous
morphological defects, comprising a patchy hair coat, bumpy, lesioned skin, keratin plugging of the hair canal,
and the expansion of infundibular and sebaceous gland populations. Loss of Sdhd is associated with an
increase in Myc expression within the hair follicle, suggesting that these malformations are driven by an
abnormal Myc-driven transit amplifying program within the upper hair follicle and sebaceous gland. These
results contrast with a recent study by our collaborator, Navdeep Chandel, which showed that Complex I, but
not Complex II, was essential for normal lung development, suggesting that individual respiratory complexes
regulate epithelial development in a lineage-specific manner. I hypothesize that loss of a functional Complex II
drives alterations in transcriptional programs, chromatin state, and gene expression via inhibition of a-
ketoglutarate-dependent epigenetic modifiers, resulting in compromised epithelial stem cell fate specification,
lineage formation, and differentiation. Here, I propose to (1) determine the function of Complex II in epidermal
fate specification and skin morphogenesis and (2) investigate the mechanisms through which Complex II
controls the epithelial cell transcriptome. Experiments proposed in Aim 1 will focus on conducting a
comprehensive phenotypic, transcriptomic, and metabolomic analysis of Sdhd cKO mice. Aim 2 focuses on the
analysis of epigenetic perturbations induced by loss of Complex II function through Cut&Run sequencing as
well as single cell multiomic identification of candidate transcriptional regulators driving the response to Sdhd
deletion in epidermal lineages. My results will provide important new insights into the role of the ETC in tissue
morphogenesis, with implications for the study of tumorigenesis, stem cell biology, and aging.

Public health relevance
Project Narrative The electron transport chain (ETC) has emerged in recent years as a major cellular signaling platform through the production of reactive oxygen species (ROS) and modulation of key metabolite availability. This project will investigate the role of individual ETC complexes in regulating skin and hair morphogenesis through deletion of Sdhd, a key member of complex II of the ETC. This work is essential to understanding the role of metabolic state in cellular fate specification within epithelial lineages and will provide valuable insights into the interplay between metabolism, epigenetic state, and transcriptional programming in health and disease.